Macrophage and Monocyte Metabolic Adaptation in Hemolysis and Sickle Cell Disease

Macrophage and Monocyte Metabolic Adaptation to Hemolysis and Sickle Cell Disease
PROJECT SUMMARY
Hemolysis is a unifying feature of a diverse set of pathologies including inherited disorders such as sickle cell
disease (SCD), infectious diseases including malaria, systemic pathologies such as sepsis, as well as drug
toxicity and autoimmune disease. The release of free heme causes oxidative damage, leading to immune cell
activation, endothelial damage, ischemia, and end-organ toxicity. Innate immune cells such as macrophages are
specialized in heme detoxification, and while it is now evident that macrophages alter their cellular metabolism
in order to carry out specific effector functions, the metabolic adaptations that allow macrophages to survive the
toxic stress of heme clearance remain unknown. Preliminary data from our group reveal that in response to heme
loading macrophages shift glucose metabolism toward the pentose phosphate pathway (PPP), which allows for
the rapid production of NADPH and maintenance of redox homeostasis. This metabolic adaptation is dependent
on the activity of heme oxygenase, and that carbon monoxide (CO) released during heme breakdown is the
mediator that induces the metabolic adaptation toward the PPP. We also find that activity of the PPP is required
for effective heme detoxification, and that the PPP is upregulated at the enzymatic and transcriptional level in a
mouse model of SCD, while, surprisingly, PBMCs from patients with SCD, PPP enzymes are downregulated
during disease exacerbation when compared with the same patient at baseline. Taken together, these data
suggest a critical role for macrophage/monocyte metabolic adaptation in the response to hemolysis, and point
toward manipulation of metabolism as a potential therapeutic avenue for treatment of heme-driven pathologies.
This proposal tests the hypothesis that carbon monoxide released by heme breakdown shifts glucose
metabolism toward the PPP and that pharmacologic manipulation of this pathway to promote the PPP promotes
heme clearance and ameliorates hemolysis-induced damage. This hypothesis will be tested through the
completion of the following specific aims. Specific Aim 1 is to determine the intracellular mechanism by which
CO drives metabolism toward the PPP: Subaim 1A tests the hypothesis that CO inhibition of cystathionine beta
synthetase (CBS) results in loss of phosphofructokinase (PFK) FB3 activity, which shunts glucose metabolism
away from glycolysis and toward the PPP. Subaim 1B then examines whether pharmacologic inhibition of
PFKFB3 can promote heme clearance and reduce hemolysis-induced damage in hypoxia-induced
vasoocclusion. Specific Aim 2 is to examine how the current SCD treatment glutamine alters immunometabolic
profile of circulating monocytes in mouse and human SCD. Subaim 2A tests in vitro and in vivo whether glutamine
alters cellular metabolism to promote the PPP and ameliorate hemolysis-induced pathology. Subaim 2B
integrates transcriptomic and bioenergetics analyses to characterize the immunometabolic status of PBMCs
from patients with SCD, to determine how metabolism is altered at steady state, during disease exacerbation, or
in response to treatment.

Public health relevance
PROJECT NARRATIVE Hemolysis contributes to problems in a variety of diseases including Sickle Cell Disease, sepsis, malaria, and drug toxicity, when ruptured red blood cells release heme into the circulation, causing vascular inflammation, oxidative damage, and end-organ injury, which leads to significant morbidity for patients with these disorders. Macrophages and monocytes are immune cells that are responsible for clearing heme to prevent damage, but the mechanisms by which they are able to survive the stress of this process remain unclear. Here we propose to examine how these cells adapt their metabolism to carry out these important functions, and to test whether manipulating these cells’ metabolism can improve heme clearance and reduce heme-induced damage.